Administrative Core

Summary: The Administrative Core of the University of Massachusetts, Boston (UMass Boston) and Dana-
Farber/Harvard Cancer Center (DF/HCC) Partnership takes an integrated approach to operational structure to
support the growth of broad-based, transdisciplinary cancer and cancer disparities research at both institutions.
Partnership PIs Drs. K “Vish” Viswanath and Gregory “Goyo” Abel from DF/HCC and Drs. Adán Colón-
Carmona and Jill Macoska from UMass Boston, lead the Administrative Core and provide complementary
expertise and abiding dedication to the sustained success of this research program. As the nucleus of the
leadership and administrative teams, the PIs, with the support of effective internal (Internal Advisory
Committee (IAC)), external (Program Steering Committee (PSC)) and institutional leaders, provide rigorous
oversight for the research projects, programs and cores, to maximize the impact of the Partnership at the
institutional level. In addition, a single Partnership Program Manager shared by both institutions creates
operational synergies in the management of this multi-institutional research collaboration.
The aims of the Administrative Core are to: 1) Provide administrative and fiscal oversight for Partnership cores
and research projects, and ensure responsible stewardship of funds; 2) Coordinate joint Partnership activities
at UMass Boston and DF/HCC and facilitate networking opportunities; 3) Ensure proper infrastructural support
for funded projects and cores; 4) Manage Partnership communications with all critical stakeholders in greater
Boston; 5) Support a new institutionally-funded DEI Manager who will leverage the expertise of the Partnership
Cores to begin to investigate reasons for faculty of color attrition, train a dedicated group of mentors for before
and after hire, and develop a new network for diverse post-docs in the Boston metro area; and 6) Track
institutional commitment in support of Partnership initiatives, particularly toward recruitment efforts for Early
Stage Investigators (ESIs) and leverage institutional resources for this effort.